Innovative Scan Protocols With Combined Long Axial FOV PET and Spectral CT for Improved Quantification in Oncology

Innovative scan protocols with combined long axial FOV PET and spectral CT for improved
quantification in oncology: The goal of this project is to i) develop methods and protocols to obtain
high-quality dynamic information from both PET and CT modalities and, ii) use dynamic Spectral CT for
PET kinetic modeling to reduce overall scan time to match existing clinical PET protocols (~20 minutes).
This technological advancement will enhance diagnostic capabilities in oncology, with broad applications
in other diseases, while also reducing the burden on patients with shorter imaging protocols. We will
achieve these goals through 3 specific aims: (1) Develop spectral CT protocol and processing pipeline
for IDIF and perfusion maps; (2) Develop advanced modeling to combine Spectral CT and PET data for
kinetic modeling; (3) Evaluate PET-Spectral CT to quantify blood flow and glucose metabolism in breast
cancer. In Aim 1 we will implement an ultra-high-pitch spectral CT protocol to generate dynamic iodine
maps with extensive axial coverage, including the blood pool and targeted tissue/organ. Our deep
learning (DL) based approach utilizes spectral CT to differentiate anatomical background from iodine
enhancement, preserving image quality and minimizing radiation exposure. We aim to improve iodine
contrast bolus delivery and timing, assessing concentration and injection/acquisition timing. In Aim 2 we
will utilize a custom flow phantom for testing and validation of the CT methods in Aim 1 methods as well
as pre- and post-reconstruction data corrections in PET. Initial assessments of the relationship between
CT, PET, and CT-informed PET IDIFs and resultant kinetic perfusion parameters will be made with the
flow phantom. In Aim 3 we will test the CT-dose reduction, bolus optimizations and PET data correction
methods developed in Aims 1 and 2 in a translational porcine model (N=4) followed by a cohort of breast
cancer patients (N=10). Patlak graphical analysis will also be implemented to compare the net influx rate
of FDG when the IF is estimated with and without CT information. These metrics will be compared across
modalities and estimation methods with the goal of developing a clinically translatable hybrid Spectral
CT-PET protocol for dynamic imaging. Our overall outcomes will be solutions that facilitate the acquisition
of high-quality dynamic information from both PET and CT, to be leveraged for PET kinetic modeling
purposes, and used for clinically practical protocols to enhance the accuracy of oncological diagnostics.

Public health relevance
In this proposal, we will develop methods that leverage the respective strengths of PET and CT to improve quantification in oncology using our novel PET-Spectral CT scanner. Specifically, we will develop dynamic Spectral CT methods, with attention to minimizing radiation dose, and use this data to inform PET kinetic modeling. Our aim is to integrate Spectral CT information into a clinical PET workflow, enabling non- invasive and fast imaging protocols to capture PET radiotracer parameters that would otherwise be unattainable.